PIC-TRFS: A Randomized Trial of a Multicomponent Intervention for ICU Survivors and Caregivers

PROJECT ABSTRACT
Each year in the U.S., over 3 million people survive critical illness only to experience long-term physical,
cognitive, and psychological impairments that contribute to ongoing morbidity, mortality, and high-cost, high-
utilization healthcare needs. Current fragmented, deficit-based health services delivery contributes to poor
outcomes and preventable rehospitalizations. In response to this gap, we used community engagement to
redesign a pragmatic, accessible, scalable, strengths-based care model that integrates 3 essential elements:
(1) transitional care management; (2) problem-solving rehabilitation; and (3) family support. The result is
the PIC-TRFS, which stands for Post-Intensive Care Transitional care, Rehabilitation, and Family Support.
PIC-TRFS is a hybrid in-person and telehealth intervention delivered by an interdisciplinary team to nimbly
support health, rehabilitation, and social care needs in collaboration with existing hospital, home health, and
primary care infrastructure across transitions from hospital to home in the six months following a critical illness
hospitalization. An ongoing pilot is demonstrating feasibility, acceptability, and engagement among survivors,
caregivers, and providers across the post-ICU continuum. This proposal represents the next step: a single-
center randomized controlled trial to establish the efficacy of PIC-TRFS. Compared to Enhanced Usual Care
(n=80), we hypothesize that PIC-TRFS (n=80) will: (1) improve survivor-and caregiver outcomes including
survivor quality of life (primary outcome), days alive at home, function, trauma symptoms, and caregiver quality
of life (secondary outcomes); and (2) reduce healthcare utilization, measured as a composite of days in a
healthcare facility, ED visits, and outpatient visits (secondary outcomes) (Aim 1). Assessing fidelity to
intervention delivery, receipt, and enactment will inform potential tweaks to PIC-TRFS and resource planning
for future implementation research (Aim 2). Finally, we will explore the extent to which clinical and social
vulnerability moderate the impact of PIC-TRFS and dyadic activation, participation, and access to community
services mediate it (Aim 3). Successful conduct of this RCT will establish the efficacy of PIC-TRFS, generate
insight into mechanisms of action, identify groups for whom it requires further adaptation to promote equity,
and inform its subsequent implementation. It will be a major step toward the goals of expanded access to high-
quality, affordable care via scalable models of integrated service delivery. It is also a pragmatic step towards
realizing the AHRQ’s broader vision for implementing learning health systems that continually innovate to
optimize the delivery of safe, effective, equitable, accessible, high-quality care.

Public health relevance
PROJECT NARRATIVE Our community engagement studies have shown that integrating 3 strengths-based intervention components, each with consistent evidence of effectiveness when studied individually in other clinical conditions (transitional care management, problem-solving rehabilitation, and caregiver support), could address unmet care needs of critical illness survivors and their caregivers when integrated. This proposal will conduct a randomized control trial to establish efficacy of the integrated intervention, Post-Intensive Care: Transitional care, Rehabilitation, and Family Support (PIC-TRFS), on survivor and caregiver outcomes including quality of life, function, survival, trauma symptoms, and healthcare utilization. Success would support PIC-TRFS as high-quality, affordable care via a scalable model of integrated service delivery that should be examined for effectiveness through broader implementation.